HIGH THROUGHPUT GENOTYPING AND DNA SEQUENCING FOR STUDYING THE GENETIC CONTRIBUTIONS TO HUMAN HEALTH AND DISEASE: WHOLE GENOME SEQUENCING FOR BEEBE-DIMMER (NCI)

HIGH THROUGHPUT GENOTYPING AND DNA SEQUENCING FOR STUDYING THE GENETIC CONTRIBUTIONS TO HUMAN HEALTH AND DISEASE: WHOLE GENOME SEQUENCING FOR BEEBE-DIMMER (NCI)